Pixelated scintillators for ultra-high resolution cone-beam CT

PROJECT SUMMARY / ABSTRACT
Indirect-detection x-ray Flat Panel Detectors (FPDs) use a scintillator to convert x-rays to light, which is then detected by
photodiodes coupled to readout electronics. During the past two decades, the latter evolved from noisy amorphous Silicon
arrays with coarse pixels (>130 µm) to low-noise CMOS sensors with very fine pixels (<100 µm). There has been
comparatively little innovation in the scintillator, which is now the principal factor limiting FPD spatial resolution. The
scintillator bur is caused by the lateral spread of light between the x-ray interaction site and the photodiodes.
To overcome this challenge, we propose to use laser ablation to pixelate the scintillator film – here, a ~700 µm thick CsI:Tl
commonly used in FPDs - at a pitch matching the readout array. We will develop Atomic Layer Deposition (ALD) techniques
to coat the high-aspect ratio pixelation grooves with an optimized combination of absorptive and reflective layers to
ensure that there is no inter-pixel cross-talk and that the majority of x-ray interaction light is directed towards the
photodiodes. To mitigate signal losses due to the loss of film volume in pixelation grooves, we will use a novel crystalline
form of micro-columnar CsI:Tl (CMS CsI:Tl) which enhances the sensor signal-to-noise ratio (SNR) by exploiting the higher
density and increased transparency of the crystalline material.
The proposed scintillator has the potential to substantially improve the performance of modern FPDs by enabling ultra-
high spatial resolution imaging without sacrificing x-ray attenuation provided by using a relatively thick CsI:Tl. We have
performed initial experimental studies of this approach and found ~20% better limiting spatial resolution than
conventional detectors. This proposal will build on this early work by (i) refining the pixelation technique to obtain even
thinner pixel grooves for better detection efficiency, and (ii) optimizing the CMS deposition process and the inter-pixel
coatings for improved light output.
Our technology will benefit applications where visualization of ~100 µm details is desired, but currently challenged by
image noise due to body size and/or patient dose: 2D and 3D angiography, pulmonology, breast, otolaryngology imaging,
and orthopedics. For an initial demonstration of potential clinical utility, we target quantitative in vivo assessment of bone
microarchitecture in osteoporosis (OP) and osteoarthritis (OA). We will pursue the following specific aims:
Aim 1: Optimize the pixelation process to maximize spatial resolution, detection efficiency, and brightness of the pixelated
CsI:Tl films. Achieve light yield approaching that of a conventional scintillator and improved SNR for ~100 µm features.
Aim 2: Validation in quantitative high-resolution Cone Beam CT of trabecular bone. Characterize of the pixelated detector
in terms of fundamental metrics of CBCT imaging performance and in 3D trabecular measurements (bone volume,
trabecular thickness and spacing) in a range of body sites pertinent to OA and OP.
The results will inform future development of other possible applications of FPDs based on pixelated scintillators with high
detective efficiency, e.g. in interventional radiology and pulmonary imaging.

Public health relevance
PROJECT NARRATIVE The proposal develops a new type of x-ray detector with an improved ability to distinguish small features (on the order of 100 µm) compared to the currently available devices. This novel technology will benefit many applications in radiology where very fine organ structures and medical instruments need to be examined – for example small lung airways, bone trabeculae, vascular stents, and brain electrodes. The validation studies in this project will focus on bone imaging to better assess trabecular changes due to osteoporosis and osteoarthritis.